Data Resource and Administrative Coordination Center for the Scalable and Systematic Neurobiology of Psychiatric and Neurodevelopmental Disorder Risk Genes Consortium

PROJECT SUMMARY / ABSTRACT
Per the FOA, this section is not required. The administrative supplement does not change the activities of the
parent award.

Public health relevance
PROJECT NARRATIVE Per the FOA, this section is not required. The administrative supplement does not change the activities of the parent award.